Roles for Mismatch Repair Proteins in Maintaining Genome Stability

Mismatch repair (MMR) factors, which act to remove DNA replication misincorporation errors, also function in
genetic recombination and in adaptation to stress. The latter two roles are the current focus of my research
efforts. Research Area 1 is centered on crossing over, a process critical in most eukaryotes for the accurate
segregation of homologous chromosomes in meiosis to form gametes. Most crossovers in baker’s yeast meiosis
result from the biased resolution of double Holliday Junction (dHJ) intermediates in steps involving Exo1 and the
Mlh1-Mlh3 MMR endonuclease, a process conserved in higher eukaryotes. Little is known about how seemingly
symmetric dHJs are resolved in a biased manner. We developed a model to explain biased dHJ resolution in
which the Exo1 protein protects nicks in or near dHJs from being ligated; this protection promotes subsequent
resolution by the Mlh1-Mlh3 endonuclease. We are testing it by developing a method in yeast to map meiotic
DNA nicks genome-wide in wild-type, exo1, and other mutant backgrounds. The data will be analyzed in
combination with Exo1 chromatin localization maps and established maps for meiotic chromatin marks and
double-strand break sites to obtain a model for crossover resolution that will be refined through analyses of
mutants displaying defects in early to late steps of meiotic recombination. Area 2 focuses on an analysis of
baker’s yeast strains containing incompatible MLH1 and PMS1 MMR alleles. Our work supports an
incompatibility model in which an elevation in mutation rate contributes to adaptation to stress conditions through
the acquisition of beneficial mutations. However, long-term fitness costs associated with an elevated mutation
rate must be eliminated by genetic suppression or buffered by mating. We will determine if signatures of
adaptation to MMR incompatibility can be directly observed in yeast populations by first screening for mutations
in PMS1 which partially or fully restore compatibility with mlh1 alleles containing mutations in different functional
domains. We will then utilize information from the 1,010 yeast genomes project to create a model for how Mlh1
and Pms1 incompatibilities arise and are eliminated during adaptation to stress. Area 3 is focused on quality
control mechanisms that act in genetic recombination. In the previous cycle we identified several chromatin
factors which play roles in homologous recombination template choice and donor template stringency. We
hypothesize that one of these factors, the SIR histone deacetylase complex, plays a role in stabilizing repair
intermediates during slow to repair events such as break-induced DNA replication (BIR) by forming filaments
adjacent to extending recombination intermediates (D-loop). We propose to track in yeast the localization of the
SIR complex during BIR and correlate its cellular localization with repair intermediates as measured by chromatin
immunoprecipitation and D-loop capture and extension assays. Our work provides an understanding for how
defects in genome integrity underlie human infertility, hereditary forms of colon cancer, fungal pathogenesis, and
diseases resulting from chromosomal rearrangements.

Public health relevance
In eukaryotes, distinct DNA mismatch repair (MMR) family proteins facilitate crossing over between homologs to ensure proper Meiosis I chromosome segregation, and act to prevent recombination between divergent DNA sequences that can lead to chromosomal rearrangements associated with diseases such as cancer. In humans, failures in meiotic chromosome segregation result in aneuploidy/infertility syndromes (at least 10% of human pregnancies), which are thought to occur as the result of Meiosis I and II errors, defective or inappropriate recombination, premature homolog separation, and defects in sister chromatid cohesion. In addition, incompatibilities in baker’s yeast MMR genes that result in elevated mutation rates have provided powerful models to gain insights into adaptation to stressful environments, identify antifungal targets, and develop strategies to limit the spread of drug-resistant fungi.